Improving Characterization of Individualized Treatment Effects in Critical Illness

PROJECT ABSTRACT
Sepsis and acute respiratory distress syndrome (ARDS) are common and potentially fatal critical care
disorders in need of improved therapeutic approaches. Developing effective treatment strategies for sepsis and
for ARDS has been challenging in part due to disease heterogeneity with variability in patient demographics,
comorbid conditions, severity of illness, inciting insults, and host response. Understanding why patients
respond differently to therapies in the intensive care unit is essential. This variability is commonly referred to as
heterogeneity of treatment effect (HTE). Recent studies identified subphenotypes in sepsis and in ARDS based
on clinical variables or biologic signatures and tested for HTE across subgroups. My recent research has
focused on an alternate method of investigating HTE by estimating individualized treatment effects (ITEs)
using machine learning-assisted approaches. Computational approaches that estimate ITEs model the
difference in an outcome for an individual on treatment versus on placebo or usual care. ITEs predict whether
a patient will benefit from or be harmed by a treatment and provide an estimate of the magnitude of benefit or
harm. ITEs vary for patients based on their unique covariate patterns and may have advantages in uncovering
treatment heterogeneity when the variables that determine treatment response differ from those contributing to
subphenotype membership. Additional tools including SHapley Additive exPlanations provide information on
variable importance for ITEs lending insight into potential mechanisms contributing to treatment response.
Preliminary studies from our group using ITE-based approaches in datasets from previously completed
randomized clinical trials have uncovered heterogeneous responses at an individual level even when no
significant difference was observed in the overall trial. Specifically, our work has yielded promising signals for
heterogeneity to (1) resuscitation strategies in sepsis using clinically available variables; (2) response to
glucocorticoids in septic shock using cortisol levels; and (3) enteral nutrition strategies in ARDS using
endocrine biomarkers. The current proposal will continue our work to improve characterization of treatment
responses in sepsis and ARDS. In this R35, we will leverage existing cohorts and biospecimen repositories to
provide biologic and mechanistic insights into the ITE signatures identified in our preliminary work. We noted in
our preliminary studies that for some treatments clinically available variables measured immediately prior to
intervention were not sufficient in predicting ITEs. Thus, in this R35, we will incorporate biologic data from
multi-omics platforms to improve and refine ITE predictions. The MIRA award will be the ideal mechanism to
fund this work as it facilitates the flexibility to rapidly adapt to new methodologies emerging in precision
medicine and will allow for the investigation of multiple therapies for sepsis and for ARDS which may vary
significantly in the variables determining treatment response.

Public health relevance
PROJECT NARRATIVE Developing effective treatments for the critical care disorders sepsis and acute respiratory distress syndrome is challenging because of significant variability in how patients present to the hospital. Newer machine learning- assisted computational models can allow for the estimation of treatment responses on an individual patient level based on unique patient characteristics. This proposal will advance studies of individualized treatment responses in sepsis and acute respiratory distress syndrome and develop tools to understand why patients may differ in response to the same treatment.